ChartGlucose4Moms: Characterizing, by Trimester, Continuous Glucose Monitoring Measurements for determining effects on Maternal & Offspring Metabolic Sequelae

PROJECT SUMMARY/ABSTRACT: Gestational diabetes (GDM) rates are on the rise in the US,
particularly among racial and ethnic minorities. GDM is associated with higher rates of large for gestational
age (LGA) infants, C-section, and serious perinatal complications, and increased long-term risks of Type 2
diabetes and morbidity in both mothers and infants. Women who get treatment for GDM are less likely to
experience perinatal complications and give birth to LGA infants than those who do not; therefore, rapid
detection of GDM may be critical to reducing perinatal complications and disparities in birth outcomes.
GDM is normally diagnosed by oral glucose tolerance testing (OGTT) at 24-28 weeks gestation, but clinically
important insulin resistance and metabolic dysfunction may be missed by not testing earlier. A metabolically
unhealthy uterine environment in early pregnancy may lead to long-term negative impacts on mother and
child, but how and when to test for insulin resistance and associated metabolic dysfunction in pregnancy is
poorly defined. More data are needed on how glucose levels and other metabolic measures change across
pregnancy to better evaluate women's metabolic risks and how those risks relate to perinatal and long-term
outcomes.
Using continuous glucose monitoring (CGM) and metabolic biomarker assays, we will describe detailed
metabolic phenotype profiles over the course of pregnancy and examine how they are associated with
perinatal and postpartum outcomes. We propose to recruit a diverse sample of 400 women in their first
trimester from Kaiser Permanente Northwest and Kaiser Permanente Hawaii and to perform CGM, OGTT,
and obtain biomarkers at 12 weeks, 20 weeks, and 28 weeks of gestation to examine how these measures
relate to each other and to perinatal outcomes. Aim 1 and Aim 3 will assess the effects of CGM variables
(Aim 1) and OGTT and other biomarkers (Aim 3) at each time point on the risk of LGA, other perinatal
outcomes, and postpartum diabetes. Aim 2 will assess the relationship between CGM variables and
diagnosis of GDM by OGTT, as well as the relationship between CGM variables and other metabolic
biomarkers. We hypothesize that dysglycemia is just one marker of a much larger metabolic dysregulation
that can be characterized through the work of this consortium. Characterizing a broader spectrum of
metabolic dysregulation and its association with adverse perinatal outcomes will lead to improved screening
regimens and treatments for pregnant women and better outcomes for both mothers and babies.

Public health relevance
PROJECT NARRATIVE Gestational diabetes (GDM) is a type of diabetes that develops during pregnancy that increases the risk of pregnancy and birth complications. New tests may allow doctors to identify women with GDM earlier and more accurately than the tests currently being used, but we need to understand them better. We will recruit 400 pregnant women and screen them using both traditional and new GDM screening tools at 12, 20, and 28 weeks of pregnancy to determine how well these tools identify women who are at risk of complications and need treatment.